Myeloid-Derived Suppressor Cells in Immunological Endotyping and Intervention of Chronic Critical Illness after Sepsis

ABSTRACT
Sepsis is a life-threatening condition characterized by a dysregulated immune response to infection leading to
organ dysfunction. It frequently occurs in hospitalized patients undergoing surgical procedures and is associated
with prolonged hospital stays and increased mortality. Despite improved in-hospital survival, 30-50% of surgical
sepsis patients will never fully recover, but develop a syndrome recently described as “chronic critical illness
(CCI)” which is characterized by persistent inflammation, immune suppression, and protein catabolism (PICS)
and poor long-term outcomes. Currently, two important critical questions continue to vex clinical intensivists: i)
why do otherwise similar surgical sepsis patients have very different clinical trajectories where some rapidly
recover while others develop CCI despite our best supportive efforts? and ii) can we “endotype” patients with
sepsis and identify subsets with different immunological responses who would benefit from individualized
interventions. We believe that current efforts to endotype sepsis have not been fully successful because they fail
to directly assess key host-pathogen responses (e.g., cells, molecules, pathways) driving immune suppression
and inflammation, instead selecting either genomic or proteomic markers of immune status which have been
shown to exhibit limited predictive power due to sepsis heterogeneity and usually small sample sizes. Our recent
efforts have highlighted the role of unresolving “pathologic myelopoiesis” and ensuing expansion of myeloid-
derived suppressor cells (MDSCs) in driving both the persistent inflammation and immune suppression in CCI
patients. The overarching goal of the PI laboratory’s research program over the next five years is to: 1) assess
whether multi-omic data of MDSCs can improve the sepsis endotyping and predict clinical trajectories than the
commonly-used static measurements based on protein levels and nucleic acid concentrations; 2) delineate the
longitudinal change in the cross-talk between MDSCs and T cells in patients with different clinical trajectories; 3)
identify potential drugs for intervention of persistent inflammation and/or immune suppression in sepsis from
FDA-approved drugs. These goals will be achieved by integratively leveraging the existing and ongoing efforts
(RM1 GM-139690 and R01 GM-139046) examining the MDSC-specific multi-omic landscape (transcriptomics,
chromatin accessibility, DNA methylation, metabolomics, clinical variables) and large-scale of bulk blood
leukocyte transcriptomes, an existent comprehensive assessment of clinical immunosuppression and functions
of MDSCs and T cells, with powerful statistical modeling and artificial intelligence (AI). We believe that only
through a complete understanding of the immunological endotypes surrounding sepsis can effective therapeutic
interventions evolve. This MIRA would support and enable the PI and his laboratory to identify and understand
immunological endotypes of sepsis, explore how MDSC driving persistent immune suppression, and how to work
towards resolving this to improve patient outcomes. The outcomes of this project will provide key data, knowledge
and drug candidates to apply precision medicine to sepsis therapy.

Public health relevance
NARRATIVE A significant proportion of surgical sepsis patients will never fully recover but develop chronic critical illness (CCI), but the means to diagnose the immunosuppressed endotype are currently limited and no effective interventions other than supportive therapies for CCI is available. Here we propose to validate myeloid-derived suppressor cells (MDSCs) genomic features as effective biomarkers for early diagnosis immunosuppression, to delineate the interaction of MDSCs with T cells, and identify potential drugs for subsequent clinical development, using multi-omics and innovative AI/statistical approaches.